Molecular and Functional Dissection of Distinct mRNA Export Pathways

Project Summary
The major cellular mRNA export factor Mex67/NXF1 (yeast/vertebrates) transports its cargo from the nucleus
through the nuclear pore complex (NPC) to the cytoplasm in a distinct ATP dependent pathway, that is
different from all other export factors that rely on the GTP/GDP-dependent Ran cycle. In most eukaryotes,
Mex67/NXF1 exists as a single protein; however, additional tissue-specific isoforms of NXF1 exist in metazoa
(i.e. humans). The functions of these tissue-specific isoforms have been difficult to delimit due to the
complexity of control of gene expression in metazoa as well as the lack of simple model systems that may
mimic different tissues. We recently discovered that Trypanosomatids, a group of divergent unicellular
protozoans, have two very distinct paralogs of Mex67 with differing roles in mRNA export. Trypanosomatids
lack individual gene promoter control, instead relying heavily on post-transcriptional gene regulation and
potentially, placing RNA export at the center of the control of gene expression. Indeed, our preliminary results
indicate that the two Mex67 paralogs have life cycle-specific roles, reminiscent of the tissue-specific NXF1
variants observed in metazoa. It is our hypothesis that these two Mex67 paralogs function to help differentially
regulate the expression of genes in different life cycle stages. To determine this, we will quantitatively and
comprehensively characterize the paralog-specific protein interactomes and RNA cargos of the two Mex67
proteins in cells in the different life stages by utilizing and adapting methods we have pioneered, as well as
standard biochemical techniques. Concomitant with an expanded role of nuclear transport in gene regulation,
we have previously shown that the trypanosomatid NPC lacks the entire ATP-dependent export machinery
required to drive mRNA export in yeast and metazoa. Instead, our results suggest organisms depend on the
Ran GTPase system, like all other transport pathways within the cell, a major departure from the canonical
textbook model of mRNA export. We hypothesize that this system will provide a new perspective on how Ran
can be utilized to mediate directional transport across the NPC. Our strategy will include classical biochemical
techniques involving exogenously expressed components that have been succesfully employed to delimit
nucleocytoplasmic transport in yeast and humans, as well as state of the art proteomic methods to compute
topological maps of the TbMex67-Ran machinery. Our results will help reveal how different organisms and
tissues may use export as an important mechanism to control gene expression, and how Ran may drive
different nuclear transport pathways in previously unanticipated ways.

Public health relevance
Project Narrative The transfer of genetic information that is encoded within our nucleus to the cytoplasm is fundamental to the maintenance of all processes in a eukaryotic cell. Trypanosomatids, a large group of single-celled protozoa have re-engineered their transport machinery, creating additional copies of transport proteins exhibiting lifecycle specific roles, similar to tissue specific transport proteins seen in multicellular organisms, whose roles are poorly understood. By studying the role of these transport proteins in trypanosomes, we have the capacity to enhance our understanding of how these proteins function in our tissues and organs, significantly advancing our knowledge of basic cellular biology, which may ultimately lead to new therapeutic interventions.